Epigenomic profiling of complex tissues with single-cell CUT&RUN

Summary
Human genetic regulatory elements remain poorly defined, in large part owing to technical
limitations of methods that have been used to map specific components of the chromatin landscape.
By far the most popular of these methods is ChIP-seq, which is used in thousands of laboratories and
is a staple of large infrastructural projects such as NIH's ENCODE and Epigenomic Roadmap
consortia. However, in 1½ years since its introduction, our novel Cleavage Under Targets & Release
Using Nuclease (CUT&RUN) antibody-tethered nuclease method has surpassed standard ChIP-seq
in efficiency and resolution by orders of magnitude. We have developed extensions to CUT&RUN
that make it more generally applicable to biological problems, and have introduced a high-
throughput automated format for research and clinical applications.
To extend the utility of CUT&RUN to heterogeneous cells and tissues, we propose to develop two
single-cell CUT&RUN strategies with distinct advantages. In both cases, we apply in situ ligation to
CUT&RUN fragments in bulk, for which we present preliminary proof-of-concept data. One strategy
uses direct barcoded amplification of CUT&RUN fragments in nanowell chip arrays and the other
uses split-pool combinatorial barcoding. To help guide technology development and to further our
understanding of important developmental pathways, we will apply single-cell CUT&RUN to
human CD34+ primary hematopoietic cells and Drosophila germline tissues. We will also develop
novel computational tools customized for CUT&RUN data that take advantage of the base-pair
precision of cleavages by using fragment length and position for peak-calling and for identification of
active genetic regulatory elements. We will use standard computational tools that have been
developed for single-cell RNA-seq data to delineate cell-type, and we will develop software for
simultaneous mapping of adjacent transcription factors, histone marks and RNA Polymerase II
within single cells to deduce enhancer-promoter-gene combinations. Finally, we will exploit the
ability of CUT&RUN to detect a new general nucleosome feature that we recently discovered in
which regulatory elements are marked by asymmetrically unwrapped nucleosomes.
Taken together, our proposal will introduce a low-cost high-throughput single-cell epigenome
characterization strategy that applies to the wide variety of basic research and clinical applications
that require information from the activity of genetic regulatory elements.

Public health relevance
Narrative Genetic regulatory elements are poorly defined in large genomes such as ours despite large-scale efforts to identify and characterize elements with sufficient sensitivity and resolution to decipher genetic regulatory networks during development and to understand genetic disease mechanisms. Single-cell RNA-seq has been revolutionizing the study of development and disease, raising the prospect of extending the single-cell approach to the inherently greater information content of regulatory elements and defining these elements directly with base-pair resolution. Our CUT&RUN technology, when coupled with a suitable single-cell barcoding strategy, has the potential of achieving this ideal in a cost-effective manner, and thus could revolutionize how the epigenome is studied in academic research and in the clinic.